Alcohol Metabolism Disrupts Hepatic Thiol Redox Signaling and Control

Project Summary
Alcohol consumption contributes to approximately 6% of worldwide deaths and is a major cause of morbidity
and mortality within the United States. These statistics support a pressing need for understanding the
biochemical mechanisms underlying alcohol toxicity and the pathogenesis of alcohol-associated liver disease
(ALD). Chronic alcohol metabolism impacts numerous cellular pathways including glycolysis, lipid metabolism,
the TCA cycle as well as antioxidant and inflammatory responses. There is a known biochemical link between
metabolic alterations, oxidative stress, and protein thiol redox switches (e.g., cysteine (Cys) residues);
however, very little information exists regarding how chronic alcohol metabolism impacts hepatic thiol redox
signaling and control networks. Our preliminary data supports the notion that alcohol metabolism, protein
acetylation, and Cys redox are highly associated. Therefore, we present an innovative approach for
investigating how alcohol metabolism impacts thiol redox signaling and control. Central to our aims, the thiol
redox proteome is an adaptive interface that provides a means to sense, avoid, and defend against oxidants
and other toxicants. Therefore, the hypothesis of this proposal is that alcohol metabolism impacts thiol redox
signaling and control through lysine acetylation, resulting in hepatic dyshomeostasis and contributing to ALD.
We will investigate the proposed specific aims to test our hypothesis: Specific Aim 1: Characterize altered thiol
redox signaling and control due to alcohol metabolism. Specific Aim 2: Utilize Sirtuin 1 overexpression to
define mechanisms of acetylation-redox signaling and control. Specific Aim 3: Integrate mechanisms of redox-
Cys and acetyl-Lys to elucidate CoAlation specific redox signaling. We will execute these research aims
utilizing a cutting-edge proteomics and bioinformatics approach to reveal novel redox sensing mechanisms
within hepatocytes. Elucidating how alcohol metabolism alters hepatic redox signaling and control through
novel post-translational modifications will support the development of targeted clinical interventions to
ameliorate ALD in millions of Americans.

Public health relevance
Project Narrative Alcohol toxicity is a leading cause of liver disease. The long-term goal of this research project is to investigate how alcohol changes protein signaling and activity in the liver through modification of cysteine and lysine amino acid residues. We will study these processes to better understand how alcohol-associated liver disease occurs and to develop targeted therapeutic interventions to protect the liver from alcohol toxicity.